Epigenetic mechanism in mammalian kidney development and tumorigenesis

Project Summary
Cellular differentiation during organogenesis relies on precise epigenetic and transcriptional regulation.
Disruptions to this regulation can lead to developmental disorders and malignancies. Wilms tumor, the most
common kidney cancer in children, accounts for 6% of pediatric cancers and exemplifies the connection between
disrupted development and tumorigenesis. While alterations in transcription factors and signaling proteins crucial
for kidney development are known drivers for a subset of Wilms tumor cases, recent studies reveal that 30-50%
of Wilms tumors harbor mutations in epigenetic regulators, whose function in kidney biology remains unexplored.
This project seeks to fill this crucial gap by investigating the role of Eleven-Nineteen-Leukemia (ENL), the most
frequently mutated epigenetic regulator in Wilms tumor, in kidney development and cancer. ENL functions as a
chromatin reader, binding to histone acetylation through its YEATS domain and recruiting elongation factors to
promote transcription. Our recent work shows that hotspot mutations in the ENL YEATS domain, found in Wilms
tumor and leukemia, confer gain-of-function properties to ENL, enabling it to drive aberrant gene activation by
forming condensates at select target genes. However, the biological functions of ENL and its mutations in normal
kidney development and pathogenesis, as well as the underlying mechanisms, remain largely unexplored. We
have developed innovative gain- and loss-of-function mouse models for ENL, and preliminary data from these
models suggest a critical role of ENL in kidney development. Our central hypothesis posits that proper ENL
activity is crucial for normal kidney development, and that gain-of-function ENL mutations disrupt normal
differentiation programs, leading to disease states contributing to Wilms tumor formation. We will test this
hypothesis using a combination of approaches, including novel genetic mouse models, patient-derived
organoids, single-cell transcriptomics/epigenomics profiling, and chemical interventions. Our objectives include
determining the biological functions of ENL and its cancer-associated mutations in kidney development at single-
cell resolution (Aim 1), investigating the role of the ENL mutation in kidney pathogenesis (Aim 2), and targeting
mutant ENL’s pathogenic function in patient-derived Wilms tumor organoids using a potent small-molecule
inhibitor we have developed (Aim 3). By elucidating the biological functions and mechanisms of ENL and its
mutations, this project will provide new insights into kidney development and pathogenesis, and potentially lead
to novel therapeutic strategies. More broadly, these findings will advance our understanding of how epigenetic
factors regulate normal differentiation programs and how their aberrations can lead to disease, catalyzing future
research into other epigenetic regulators in Wilms tumors and other diseases.

Public health relevance
Project Narrative Wilms tumor, the most common kidney cancer in children, frequently harbors mutations in epigenetic regulators, notably ENL, whose functions remain unexplored. This project aims to elucidate the roles and mechanisms of ENL and its mutations in normal kidney development and pathogenesis, and to determine the efficacy of a novel ENL inhibitor we have developed in patient-derived Wilms tumor models. These studies will provide new insights into epigenetic mechanisms in kidney development and tumorigenesis and potentially lead to novel therapeutic strategies.